Immune evasion mechanisms of the Borrelia

: NOTE: The primary modification to the abstract below is that the sentence indicating that we will have to develop a genetic manipulation sysfrytem has been deleted. This has been accomplished and as a result that language has been re-phrased to reflect this. ,r- -4- -C) Other aspects of the abstract did not require revision f13 The Borrelia are causative agents of important human diseases including Lyme disease and relapsing fever. In N. America, Lyme disease is caused by B. burgdorferi, B. garinhi, and B. afzelii and relapsing fever is caused by Borrelia hermsii and B. turicatae. Both infections are multi-systemic disorders with potentially serious clinical outcomes. Lyme disease is a significant problem in endemic regions of the United States and Europe with over 75,000 cases per year. Several recent outbreaks of relapsing fever have occurred in N. America and Europe and the disease remains a continuous problem in Africa. A key pathogenic feature of the Borrelia is their ability to evade early immune-mediated destruction and persist in mammals. Several y++ v-. E>L'cm gin' can 3;M .gym vii complement and opsonophagocytosis is through the binding of members of the factor H (FH) cell adhesion and cell spreading. These proteins are abundant in serum, interstitial fluids, and family of complement regulatory proteins. The host produced-FH proteins normally function as contributing mechanisms have been identified. One means by which the Borrelia circumvent negative regulators of the alternative complement cascade and play an important role in host -.r- U)> C.- adherence and tissue invasion. The contributions of the FH-pathogen interaction in urine and are found in association with platelets, blood cells, anchorage dependent cells basis of the FH/FHL-1-microbe interaction, further characterize a newly defined interaction pathogenesis are now firmly established. The aims of this proposal are to define the molecular means to down-regulate complement at the cell surface and as a means of facilitating (endotheliurn, epithelium) and the extracellular matrix (ECM). Pathogens exploit FH binding as a -Op 5== CAD U-0 between Borrelia FH binding proteins and additional serum proteins including plasminogen and with a wide range of human pathogens. obtained in understanding the molecular basis, and biological role of the FH/FHL-1 interaction the Borrelia. The broader significance of this proposal lies in the applicability of the information our understanding of the molecular pathogenesis, persistence and adherence mechanisms of relapsing fever spirochetes as a model. In summary, the analyses proposed here will enhance utilize genetic manipulation to dissect the contributions of these virulence mechanisms using the ''- [unreadable][unreadable]'"0_ an' N-0 n"30-om3.o -O= (it

Public health relevance
Please note that this section has not changed or been modified. The in formation below accurately reflects the public health relevance of the revised proposaL Numerous human pathogens including the Lyme disease and relapsing fever Borrelia exploit interactions with host produced proteins to establish initial infection and maintain persistent infection. This proposal will further characterize the microbial proteins produced by relapsing fever spirochetes that contribute to immune evasion, adherence and tissue invasion. 0)U,(6 -ti :L-